Behavioral Research Mentorship in Diabetes for Early Career Scientists from Diverse and Underrepresented Groups.

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) management is particularly challenging during periods of transition, such as at new
diagnosis, early adolescence, when changing treatments, and during the transition from pediatric to adult care.
Difficulties with self-management and increased risk for worsening glycemic and quality of life outcomes often
accompany these challenging periods. Despite decades of behavioral research, there are few empirically
supported behavioral interventions with proven efficacy to improve these outcomes. With foundations in the
science of behavior change and positive psychology, the Resilience and Diabetes (RAD) Behavioral Research
Lab at Baylor College of Medicine (BCM) and Texas Children’s Hospital (TCH) conducts strengths-based
research that aims to promote positive psychosocial and medical outcomes in young people with T1D and their
family members. The Principal Investigator, Marisa Hilliard, PhD, is a behavioral scientist and psychologist who
leads the multidisciplinary RAD Lab research team and mentors learners, including post-baccalaureate research
staff, graduate students, postdoctoral fellows, and junior faculty. Many of Dr. Hilliard’s current mentees identify
as being from racial, ethnic, and socioeconomic groups that are underrepresented in science, and she has
sought focused training related to providing research mentorship with attention to the experiences and needs of
mentees with diverse identities. She has been recognized for excellent research mentorship and seeks to further
strengthen her skills to build a pipeline of well-trained, diverse early career researchers in the field of behavioral
diabetes science. This K26 proposal aims to strengthen Dr. Hilliard’s skills and capacity to provide personalized,
culturally aware research mentorship to diverse early career researchers interested in behavioral diabetes
research, both within the RAD Lab at BCM and TCH and at other institutions. With the protected time afforded
by the K26, Dr. Hilliard will engage in two primary mentorship-related activities: (1) expanding her capacity to
provide individual and group-based research mentorship to mentees using data from her NIDDK-funded R01s
and other research grants focused on behavioral aspects of living with T1D, and (2) strengthening her skills in
research mentorship through continuous, individual mentorship coaching from national experts who will guide
her in learning and applying skills for anti-racist, culturally aware research mentorship, using a systematic
approach to identifying and fostering mentee strengths, and applying a developmental lens to supporting
research success and professional development for mentees from various disciplines and skill levels. She will
participate in workshops for research mentorship skill development at least annually. To recruit additional early
career mentees from underrepresented backgrounds who have interests in pursuing research training and
careers in behavioral diabetes, she will partner with BCM and TCH pre- and postdoctoral training programs in
Pediatric Diabetes and Endocrinology and Psychology, BCM graduate programs focused on supporting learners
from underrepresented groups, and local and national research training programs and student organizations.

Public health relevance
PROJECT NARRATIVE Despite decades of research about the centrality of behavioral and psychosocial factors in supporting health and mental health outcomes of people with diabetes, there are few empirically supported interventions in the field, and a larger, more diverse field of well-trained behavioral scientists is needed to make progress. This K26 proposes to expand Dr. Marisa Hilliard’s capacity to provide in-depth, strengths-based, culturally aware research mentorship to a diverse, multidisciplinary group of graduate students, postdoctoral fellows, and other early career researchers interested in behavioral research for youth and young adults with type 1 diabetes and their families. To strengthen her skills for working with a highly diverse pool of mentees, Dr. Hilliard will engage in targeted research mentor training experiences and receive individual coaching from two established mentorship experts, focusing on fostering an anti-racist, culturally aware mentorship approach that is tailored to learners’ individual strengths, developmental level, and goals.